Early Intervention for Youth At-Risk for Bipolar Disorder

Project Summary
The most potent risk factor for the development of bipolar disorder (BP) is a first-degree family member with
the illness; individuals with family history typically experience early BP onset and severe course. Up to 25%
of offspring of parents with BP (OBP) develop BP by young adulthood. Using longitudinal data from the
Pittsburgh Bipolar Offspring Study (BIOS MH60952), we developed a clinical tool (“risk calculator”) that
reliably predicts an individual OBP’s 5-year risk for BP using a subset of demographic and clinical variables.
This innovation offers the ideal opportunity to identify OBP at greatest risk and deliver indicated preventive
interventions. Yet, to date, there is no evidence-based intervention for OBP who have not already developed
mood disorder. Per the experimental therapeutics framework, promising approaches should be informed by,
and target, factors that cause and sustain illness. Evidence suggests the pathway to develop BP among
biologically vulnerable youth involves sleep and circadian disturbances. We adapted Interpersonal and
Social Rhythm Therapy (IPSRT), an evidence-based treatment for BP adults that helps stabilize sleep/
circadian patterns, for adolescent OBP. In an open pilot and subsequent R34 randomized trial (MH091177),
we established a preliminary efficacy signal for IPSRT with OBP. Our data further indicate IPSRT, but not
Community Treatment Referral (CTR), engages and alters the hypothesized mechanism of action--sleep/
circadian disturbance, although practical barriers impacted treatment attendance. This proposal represents
a vital next step in this program of research: a confirmatory efficacy trial of IPSRT delivered via telehealth for
OBP (age 12-18, n=120) at elevated risk for BP onset via risk calculator score. All participants receive a
baseline clinical assessment of psychiatric symptoms and sleep disturbance (via objective and subjective
methods), followed by a feedback session. Youth are then randomized to receive 8 sessions of IPSRT or a
manualized Healthy Lifestyle Behaviors Program (HL) delivered via secure videoconference to enhance
attendance and reach. As clinically indicated, youth are offered CTR for any psychiatric symptoms/disorders
identified at intake. Primary outcome domains over 18 months include subthreshold mania and affective
lability--2 potent near-term predictors of BP in OBP that are themselves associated with morbidity and
impairment. We will also further investigate the hypothesized mechanism underlying IPSRT-sleep/circadian
disruption--across levels of analysis using reliable, cost-effective methods (actigraphy and daily diary
ratings), and the contribution of interpersonal stress to sleep/circadian disruptions. Application of
Implementation Science methods throughout maximizes ultimate scalability and feasibility if efficacious. We
will also examine whether passive cellphone sensing may serve as a portable, cost-effective measure of
mechanisms and outcomes to enhance ultimate dissemination. Research in this area has the potential to
prevent, delay, or ameliorate the progression of this chronic and devastating illness in those at highest risk.

Public health relevance
Project Narrative Bipolar disorder is a severe and chronic illness associated with significant functional impairment, enormous public health costs, and high rates of suicide. Offspring of parents with bipolar disorder are a particularly high- risk group who typically display early onset and severe course of illness. Thus, effective and readily disseminable early assessment and intervention for the children of parents with bipolar disorder focused on specific, readily measurable, and modifiable risk factors has the potential to prevent or ameliorate the progression of bipolar disorder in those at highest risk.